Admin Core (FABRIC)

Bridge2AI: a FAIR AI BRIDGE Center (FABRIC) Administrative Core Summary
The Administrative Core of the FAIR Bridge2AI Center (FABRIC) will organize the five other Cores
into a highly integrated organization. It will facilitate the interaction of highly experienced
investigators from five institutions that lead the following Cores: (1) Teaming (UC San Diego), (2)
Ethics (Vanderbilt), (3) Standards (University of Texas Health), (4) Tool Optimization (Broad
Institute), and (4) Skills and Workforce Development (Charles Drew University). The specific aims
for the Administrative Core are to: (1) Organize the structure for the Consortium and serve all
logistic functions; (2) Ensure the whole Consortium follows all policies for reporting and inclusion,
and help evaluate Consortium products and activities; (3) Coordinate communications within and
across Cores, Data Generation Projects (DGPs), and the NIH. The structure will include a
Steering Committee and an External Advisory Board, a web portal that will assist users in finding
data, tools, protocols, and guidelines, as well as an innovative approach to track access to and
utilization of various Bridge2AI products and activities. An immutable ledger and smart contracts
from blockchain technology will be used to provide a decentralized platform that will help monitor
provenance, (re)use of assets, and attribution. This will facilitate reporting and promote
transparency, while also avoiding dependence on a single institution to maintain the tracking. The
Administrative Core will also keep track of milestones and timelines, including activities described
in the Plan for Enhancing Diverse Perspectives, and work together with the Teaming Core to
make sure the various Cores and DGPs are fully integrated into the Consortium and all voices
are heard. All resources created by FABRIC will be made freely available and easily accessible
via its web portal.